Resolving the relationship between mitochondrial dysfunction and the impact of non-syndromic autism spectrum disorder-related risk genes on neuronal structure and function

PROJECT SUMMARY
Despite great progress has been made in identifying hundreds of risk genes in autism spectrum disorders
(ASD), we know little about modifiers that may exacerbate or ameliorate disease severity and thus can explain
this highly heterogenous and extremely complex condition. Here we put forward the innovative “two-hit”
hypothesis that posits that coexpression of molecular variants in individual risk genes associated with non-
syndromal autism (“hit one”) and molecular variants underlying suboptimal mitochondrial function i.e., impaired
neuronal bioenergetics (“hit two”) leads to impaired neurodevelopment, synaptic plasticity, and neuronal
network phenotypes explaining the etiology of ASD. First, we will establish “two-hit” hiPSC lines, presenting
with impaired neuronal bioenergetics caused by 30% of mtDNA heteroplasmy and deficiency in PPP2R5D or
SHANK3 or GRIN2B autism relevant risk genes. Next, we will test our hypothesis in two specific aims. In
specific aim 1, we will resolve the relationship between suboptimal mitochondrial function and the impact of
molecular genetic defect in PPP2R5D, SHANK3 or GRIN2B genes on neuronal development and synaptic
plasticity. We will image “two hit” iNeurons and 3D brain organoids to reconstruct neurons and neuronal
networks as well as quantify soma size and dendritic morphology. We will also assess the number of synapses
by quantifying presynaptic Synapsin 1/2 puncta on MAP2-positive dendrites. Finally, in 3D brain organoids, we
will assess the production of radial glial cells and the production of cortical neuron subtypes expressing
markers found in cortical layers. In specific aim 2, we will delineate that neuronal network-level phenotypes
observed when disease-associated autism risk variants (PPP2R5D, SHANK3 or GRIN2B ) are expressed in
neurons with suboptimal mitochondrial function. We will first examine and compare the spontaneous activity of
neuronal networks, assess difference in the level and pattern of synchronous activity, neuronal network burst
firing rate, mean firing rate, burst duration, inter-burst intervals, and the percentage of random spikes using
multiple electrode array assays.
This innovative hypothesis reinterprets the complexity of the genetics and pathophysiology of ASD in the
context of neuronal bioenergetics. The proposed studies will also establish improved disease relevant in vitro
neuronal models that will (A) overcome current limitations, (B) facilitate the development of novel testable
etiological theories and (C) provide insights into disease modifiers, a knowledge that is currently lacking.

Public health relevance
PROJECT NARRATIVE Using advanced in vitro neuronal imaging and multiple electrode array electrophysiology technology, we endeavor to establish the functional consequences of shared contribution of impaired neuronal bioenergetics and autism risk genes and provide a new assessment for the assignment of pathogenicity. Our aims are to delineate the impact of impaired neuronal bioenergetics on neuronal development and structure associated with non -syndromic autism risk genes (Aim 1) and characterize functional electrophysiological features (Aim 2). These studies will transform our current understanding of the functional significance of impaired neuronal bioenergetics in autism spectrum disorders and on the long-term guide the development of precision medicine for autism spectrum disorders.